Illuminating the Druggable Genome Resource Dissemination and Outreach Center (IDG-RDOC)

PROJECT SUMMARY
As the Human Genome Project (HGP) approached its successful conclusion, NIH was in the process of
formulating the Roadmap, which evolved into the Common Fund. At the leading edge of these initiatives was
the Biomedical Engineering Research Partnership (BRP), which promoted technology development. For the
BRP, Sklar led the development of high throughput flow cytometry, a screening technology which transitioned
into the Molecular Libraries Program (MLP), a logical successor to the HGP, to develop small molecule probes
for newly discovered genomic targets. For the Common Fund, Illuminating the Druggable Genome (IDG)
became the next logical successor to prioritize genomic targets for further investigation. The technology
advanced via the BRP by Sklar became a foundation for the collaboration with Oprea resulting in 10 years of
participation in the MLP through both pilot and production phases, with Sklar leading both administrative and
laboratory efforts and Oprea leading the data science efforts. Toward the end of the MLP, Oprea, Sklar, and
Schürer, who had also been part of the MLP since the pilot phase, joined forces for the BARD initiative (2012-
14) and again in Phase I (2015-17) and this Phase II IDG proposal (2018-24).
Despite steady progress in developing novel therapeutics and their enormous medical and societal benefits,
current drugs target only a small fraction of the human proteome. Even drugs in clinical development and most
preclinical drug discovery research ignore a significant portion of the druggable proteome. Through the
development, broad dissemination, and use of community scientific resources, the IDG program is focused on
advancing research to study human proteins for which publicly available information or active research is
currently lacking, in order to catalyze the discovery of novel biology with a particular focus on understudied
members of the protein kinase, ion channel, and non-olfactory GPCR families.
Our highly-coordinated team from the University of New Mexico and the University of Miami will establish the
IDG Resource Dissemination and Outreach Center (RDOC) to facilitate widespread access to consortium-
generated data and resources as well as to serve the overall administration of the IDG Consortium and its
relationships with external partners. The IDG-RDOC will work with all IDG Consortium investigators to collect
and curate information regarding critical tools and reagents being developed by the IDG Consortium and
disseminate them through the IDG Portal. Specifically we will: (i) coordinate and support the IDG consortium
via a highly experienced administrative team; (ii) facilitate and coordinate external partnerships, outreach, and
training related to IDG program activities; and (iii) develop and implement data standards, policies, operations,
and tools to collect, curate, identify, and disseminate IDG-generated resources in accordance with (extended)
NIH FAIR (Findable, Accessible, Attributable, Interoperable, Reusable, Reproducible) principles.
1"

Public health relevance
PROJECT NARRATIVE Only a small fraction of opportune biological disease mechanisms are currently being considered in drug discovery research. The Illuminating the Druggable Genome (IDG) program is advancing research to prioritize the most promising, yet poorly studied opportunities for developing novel therapeutics. The Resource Dissemination and Outreach Center (RDOC) will coordinate the IDG consortium, implement an integrated outreach and training program, and facilitate the widespread dissemination of resources developed in the project to maximize their scientific impact and the success of the program.